Team-Based Connected Health to Improve Access and Outcomes in Atopic Dermatitis

PROJECT SUMMARY / ABSTRACT
Skin diseases account for 30% of all physician office visits. In the United States, access to dermatologists
remains a significant challenge for those in underserved or rural communities. To increase access to
specialists and improve patient outcomes, we will evaluate a team-based connected health (TCH) model that
enables structured asynchronous online interactions among patients, primary care providers (PCPs), and
dermatologists. The goal of TCH is to enable effective management of chronic skin diseases via high-quality
and efficient online care between providers and patients. TCH purports to bring direct and expedient specialist
care to patients and PCPs in a location-independent and asynchronous manner.
Specifically, TCH offers several ways that patients and providers can communicate online asynchronously to
manage skin diseases: (1) PCP-dermatologist, (2) patient-dermatologist, and (3) patient-PCP interactions. With
PCP-dermatologist interactions, PCPs can access dermatologists online asynchronously for consultations or to
request a dermatologist to assume care of patient’s skin disease. With patient-dermatologist interactions,
patients can upload clinical images and history online and obtain asynchronous evaluation and
recommendations from dermatologists directly. Finally, PCPs have the option of managing their patients’ skin
diseases online. Importantly, TCH applies efficient workflow that maximally supports providers and fosters
multi-directional, informed communication among patients, PCPs, and dermatologists.
To evaluate the impact of TCH, we use atopic dermatitis (AD) as a disease model. AD is a common, relapsing
inflammatory skin disease affecting 32 million individuals in the U.S. AD is characterized by intense itching and
red, scaly patches. It incurs significant morbidities and high healthcare costs. To address skin inflammation,
itch, and psychosocial consequences, PCPs and dermatologists need to adopt a team-based approach to
effectively manage all aspects of AD.
The primary goal of the proposed research is to test whether the online TCH model results in equivalent
improvements in disease severity and quality of life, provides better access to specialist care, and is cost-
saving as compared to usual in-person care in pediatric and adult patients with AD. Specifically, we will
conduct a pragmatic, cluster-randomized controlled equivalency trial and use validated measures to compare
AD disease severity, health-related quality of life, and access to care between TCH and in-person care. We will
also compare costs of the two healthcare delivery models from a societal perspective by conducting cost-
minimization and sensitivity analyses. This proposal evaluates a significant innovation in specialty-care delivery
that will likely result in improved patient outcomes, greater access to specialists, and cost savings. The study
findings will be highly impactful and have immense dissemination potential to the management of many other
chronic diseases.

Public health relevance
PROJECT NARRATIVE Many patients with chronic skin diseases suffer from poor health outcomes because they lack regular access to dermatologists. We will evaluate an online model that enables high-quality and efficient online care for patients with atopic dermatitis; we will determine whether this online model can improve access, reduce disease severity, improve quality of life, and save healthcare costs. If successful, this online model has a high potential to transform healthcare delivery for patients with chronic diseases.